Neurophysiology of Melanopsin Photoreceptors

PROJECT SUMMARY
Intrinsically photosensitive retinal ganglion cells (ipRGCs) are neurons of the mammalian eye that capture light
with a molecule called melanopsin, triggering a phototransduction cascade to generate an electrical response.
This response influences dozens of brain regions and is essential for light’s normal regulation of processes that
include the circadian clock, sleep, mood, and pupil constriction. Our preliminary experiments reveal ipRGC
response features that are suited to these processes and qualitatively distinct from those of the classic rod and
cone photoreceptors. We propose to characterize these response features, learn how they arise from
molecular mechanisms within ipRGCs, and define how they shape signals sent from ipRGCs to the brain. We
will apply patch-clamp electrophysiological recording to the ex vivo mouse retina and its isolated cells,
introducing methods that increase the physiological relevance of our findings. Our experiments will strengthen
the basic understanding of ipRGCs, sensory transduction, and ion channels. They will also provide insight into
the broad question of how cells of particular types are tailored to specific tasks.

Public health relevance
PROJECT NARRATIVE In addition to supporting sight, light regulates diverse aspects of physiology and behavior. In mammals, the intrinsically photosensitive retinal ganglion cells are essential for this regulation. We propose to develop basic knowledge of these cells and thereby deepen the foundation for improving health; for example, light acts through ipRGCs to regulate the circadian clock, and circadian dysregulation is implicated in cancer, cardiovascular disease, metabolic disorder, and mental illness.